AOU CE ADMIN SUPPLEMENT

DESCRIPTION (provided by applicant): With 33 years of experience in providing the service, the Health Sciences and Human Services Library of the University of Maryland, Baltimore (UMB) seeks to continue a Regional Medical Library Program supporting the Southeastern/Atlantic Region. UMB proposes a systematic approach to the project by establishing a governance and feedback structure; cultivating a network that provides access to biomedical and health information to all; building capacity through training, exhibits, and funding of outreach; conducting continual assessment of the program; and cooperating with the other RMLs and national NN/LM Offices to reduce duplication of effort and emphasize regional expertise. The approach is integrated, with each area depending upon the other for success and feedback.

Public health relevance
Project Narrative The NN/LM proposes to ensure equal access to biomedical and health information to a variety of users including health professionals and lay persons. This will result in better health outcomes for the Southeastern/Atlantic region because health professionals will have the best evidence for decisions, health researchers will have the latest knowledge in their fields, and consumers may make informed decisions about their own healthcare and that of their friends and family.